Administrative Core

The National Institute on Drug Abuse’s (NIDA) Justice Community Overdose Innovation Network (JCOIN 2.0)
provides an opportunity to advance the criminal legal system (CLS) as a provider of services, particularly for
those with opioid use disorders (OUD) or other substance use (SU) behaviors who are at risk for overdose. The
Administrative (Admin) Core is co-led by Dr. Faye Taxman and Ms. Amy Murphy with Dr. Carrie Pettus and
collaborators from each Coordination Translation Center (CTC) Core and proposed CTC affiliates. The proposed
Admin Core for JCOIN 2.0 is the same team that led JCOIN 1.0, with the addition of Dr. Henderson who will
assist the CTC in engaging minoritized communities, practitioners, and scholars. The CTC team represents a
diverse and experienced cadre of scholars, practitioners, and people with lived experience (PWLE) in the CLS
and team members with expertise in overdose and SU prevention and treatment. The Admin Core will serve the
critical function of being the communication center that allows for the receipt and transmission of all resources
regarding JCOIN initiatives. The Admin Core and its website and social media outlets serve as a comprehensive
resource for researchers, policymakers, treatment providers, CLS professionals, PWLE and their loved ones,
and the general public. The CTC Admin Core will provide support to NIDA, funded research Hubs (Hubs),
Methodology and Advanced Analytics Resource Center (MAARC), Advisory Panel(s), the JCOIN Steering
Committee (SC), and other CTC Cores. The Admin Core proposes to pursue three aims. Aim 1: Maintain and
enhance external-facing communications infrastructure established in JCOIN 1.0 and expand that infrastructure
in JCOIN 2.0. Admin Core diffusion of information will be measured by website engagement, social media reach,
podcast downloads, and diversity of characteristics and backgrounds of individuals consuming disseminated
content. Aim 2: Provide internal collaboration and communication infrastructure and logistical support. In JCOIN
2.0, the Admin Core will focus benchmarks for success around the use and enhancement of communication
infrastructure, ease and frequency of infrastructure use, development of publications and toolkits, and successful
support for the JCOIN SC. Aim 3: Monitor network outputs. This aim will be achieved through positive
collaboration among the JCOIN community and external stakeholders, and timely and innovative reporting to
NIDA and grantees. The Admin Core maintains a highly utilized JCOIN website that has been enhanced in each
year of JCOIN 1.0. The Admin Core aims to add enhancements during JCOIN 2.0 including a) an Opportunity
Board; b) JCOIN Events Calendar; c) Sensitivity readers and inclusive language bots; d) Diverse audience
augmentations; e) Public and private dashboards; f) JCOIN Town Halls; and g) Educational and Artificial
Intelligence features. JTEC will continue and expand in JCOIN 2.0, which is a dynamic online learning center
that reached thousands in JCOIN 1.0 with courses, webinars, and podcasts widely available.